Signal-dependent regulation of cardiac progenitor proliferation

Title: Signal-dependent regulation of cardiac progenitor proliferation
Project Summary
Deciphering signal-dependent coordination of cardiomyocyte proliferation during
prenatal growth is essential for the diagnosis and treatment of congenital heart
disorders. The complexity of this process in vertebrates has hindered progress. We have
begun to exploit the extreme cellular simplicity of Ciona robusta, a close evolutionary
relative of the vertebrates, to investigate potentially conserved roles for signals in
coordinating cardiomyocyte lineage division dynamics. Our current hypothesis is that
regional signals coordinate proliferation across distinct sub-populations of cardiac
progenitors. This hypothesis is supported by evidence from our preliminary data
indicating that - 1) there are two Ciona cardiomyocyte progenitor populations that exhibit
distinct division patterns and proliferative frequencies, 2) sub-populations of cardiac
progenitors express distinct sets of receptors and 3) disruption of candidate signaling
pathways disrupts division in one of these progenitor populations. The proposed specific
aims focus on determining whether regional signals directly mediate population specific
proliferation patterns or indirectly influence proliferation by regulating progenitor lineage
fate specification. Our efforts will initially focus on characterizing cardiomyocyte
progenitor cell division dynamics. We will then identify candidate signaling pathways by
using our scRNA-seq data to assess expression of signaling ligands and receptors
within distinct progenitor cell types and surrounding cells. We will then begin to elucidate
the role of candidate signals in cardiomyocyte lineage division and fate specification
through targeted loss of function assays. These efforts will provide intensive research
opportunities for a diverse group of undergraduates.

Public health relevance
Project Narrative: Human heart defects are pervasive and the underlying causes are often poorly understood. We are using sea squirt embryos, simple marine invertebrates with a surprisingly close relationship to humans, to study heart growth. By identifying heart stem cells and how they drive heart growth in this simple animal, we aim to unravel the much more complex contribution of stem cells to human heart growth and how errors in this process may compromise the function of this critical organ.